CORE--SCID MOUSE SKIN XENOGRAFT

The SCID Mouse: Skin xenograft core utilizes severe combined immunodeficient (SCID) beige double mutant mice to provide reproducible sustenance of human skin (and skin-related cells) in the form of split thickness skin grafts or synthetic skin constructs. The three specific aims of the core are (1) to provide members of the YSDRC (both established and junior investigators, including investigators with YSDRC P/F projects) with limited numbers of C.B-17 SCID/beige mice engrafted with healthy adult human skin or skin constructs for use in a variety of skin disease-related studies, including feasibility studies; (2) to train members of the YSDRC in generation of such mice once feasibility has been established; and (3) to develop variant models of this technique for new and novel applications.